Transcriptional regulation of post-embryonic neuronal maturation

PROJECT SUMMARY
During the complex and intricately-timed sequence of nervous system development and maturation, significant
and persistent disruptions to the dynamic regulatory process through genetic and environmental risks can
result in neurodevelopmental disorders. Neuroscience research has contributed much to our understanding of
early neural development in the embryonic and perinatal periods including neuronal specification, neuronal
migration, axonal guidance/outgrowth, and synaptogenesis. The period from early post-natal life to young
adulthood is equally critical for proper development of the mature brain, as extensive structural and behavioral
plasticity are observed during these periods. However, much less is known about the molecular regulatory
mechanisms underlying neuronal maturation during post-natal development. In my post-doctoral work/K99
phase of the award, I developed and optimized a method to isolate single neuron types for genomics profiling.
Using this method, in combination with the genetic amenability of the C. elegans system, I profiled the
transcriptome and chromatin accessibility of the nervous system throughout early post-natal development to
young adulthood and identified a conserved pathway, initiated by the microRNA lin-4 (mir-125 in vertebrates),
that controlled many but not all developmental-regulated, neuron-specific gene expression changes that
underlie neuronal maturation. In Aim 1, using the genomic profiling data as an entry point, I will take a 2-
pronged approach to identify additional, novel regulators of neuronal maturation. First, I will implement
bioinformatics tools to extract common cis-regulatory motifs from developmentally regulated genes and
predict/test candidate transcriptional regulators. Second, using validated developmentally-regulated gene
reporters from my profiling, I will conduct unbiased forward genetic screens to identify novel regulators of
neuronal maturation. In Aim 2, I will use advanced neurotechnology tools to examine the role of environmental
stimuli (sensory-induced neuron activity) on neuronal maturation. First, I will examine how acute and chronic
inhibition of activity in target neurons, during different developmental windows, affects single neuron
developmental transcriptomes and chromatin accessibility. In addition, the interaction between pathways
regulating neuronal maturation through environmentally-induced activity versus intrinsic genetic mechanisms
will be examined using approaches as in Aim 1. The proposed research will increase our understanding of the
genetic and environmental regulatory mechanisms underlying normal post-natal neurodevelopment, improve
our understanding of the etiology of neurodevelopmental disorders, and reveal novel therapeutic targets. The
successful completion of this project will provide a platform for future experiments aimed at understanding
gene-environment interplay in the transcriptional regulation of nervous system development and function.

Public health relevance
PROJECT NARRATIVE Significant and persistent disruption to the dynamic gene regulatory process during neurodevelopment through genetic and environmental risks can lead to neural disorders such as Intellectual Disability (ID) or Autism Spectrum Disorders. The goal of this research proposal is to identify the transcriptional regulatory mechanisms by which intrinsic genetic factors and extrinsic environmental factors control post-embryonic neuronal maturation. This work will contribute to a novel understanding of neurodevelopmental disease vulnerability and will inform new therapeutic targets.